MOLECULAR CHARACTERIZATION OF THE MITOCHONDRIAL DNA POLYMERASE

Summary of Work: Human mitochondrial DNA evolves faster and is more prone to oxidative damage than is nuclear DNA. Point mutations and deletions in this mitochondrial genome give rise to a wide range of mitochondrial dysfunctional diseases, such as Leber's hereditary optic neuropathy, retinitis pigmentosa, Kearn-Sayre syndrome, Pearson marrow pancreas syndrome and ocular myopathy. More than 1 in 4,000 children born in the United States each year will develop a mitochondrial disease by age 10 with a mortality rate from 10 to 50 percent. Defects in mitochondrial function have been linked to many of the most common diseases of aging. Over 50 million people in the US suffer from chronic degenerative disorders involving mitochondria of compromised function. These mutations may occur during replication by the DNA polymerase gamma. The DNA polymerase gamma differs form the nuclear DNA polymerases due to its sensitivity to antiviral nucleotide analogs, such as AZT and dideoxynucleotides. How the mitochondrial DNA polymerase makes point and deletion mutations and what structural properties set this polymerase apart from the nuclear DNA polymerases to give rise to its inhibition patterns are poorly understood. To address these questions we previously cloned the DNA polymerase gamma genes and cDNA from S. pombe, D. melanogaster and Homo Sapiens. The stability of the CAG trinucleotide repeat region in the first exon of the human DNA polymerase gamma gene was studied in DNA from patients who have suffered mitochondrial dysfunctional diseases. The recombinant human mitochondrial DNA polymerase gamma protein has been functionally overexpressed greater than 100 fold in insect cells by a recombinant baculovirus and in E. coli. The recombinant pol gamma has been purified to homogeneity and enzymatically characterized. A panel of monoclonal antibodies were produced against the catalytic subunit of the DNA pol gamma to help in the purification and aid in the study of protein interaction and regulation. We have amplified the second subunit of the DNA polymerase gamma and are currently attempting to overexpress the protein. We have initiated a program of screening for nuclear mutations that increase the spontaneous reversion rate of a mutated locus in the mitochondrial DNA. We are using a mutant locus, mt arg8, removed from the nuclear genome, recoded for mitochondrial translation and inserted into the mitochondria genome. A yeast strain carrying the mutant arg8 locus in its mitochondrial DNA has been subjected to EMS mutagenesis and screened for an increased frequency of reversion on media lacking arginine. This screen should identify genes involved in maintaining the integrity of the mitochondrial genome.